Orexinergic neurons, ethanol dependence, and voluntary ethanol consumption

Project Summary
Alcohol use disorder (AUD) is a prevalent, affecting over 10% of Americans, with only a fraction of individuals
seeking treatment. Chronic alcohol exposure induces maladaptive changes in neuronal physiology, particularly
within neural circuits that mediate reward and consumption behaviors, hallmarks of AUD that render treatment
difficult and increases the likelihood of relapse. Despite substantial progress in understanding neurotransmitter-
mediated changes in AUD, the role of neuropeptides such as orexin (hypocretin) remains underexplored. Orexin
is a hypothalamic neuropeptide that contributes to a number of physiological conditions, including regulation of
arousal, feeding, and stress. Orexinergic neurons from the lateral hypothalamic area (LHA) innervate a number
of brain regions implicated in AUD, such as the ventral tegmental area (VTA) and nucleus accumbens (NAc). In
my preliminary data, I have found that chronic voluntary EtOH consumption leads to activation of orexinergic
neurons in the LHA in male and female C57BL/6J mice. Furthermore, I have demonstrated that I can track
orexinergic activity in a free-moving mouse while it is consuming EtOH through the use of fiber photometry and
the orexin peptide sensor, OxLight1. This proposal aims to investigate the impact of alcohol dependence on
orexinergic circuits, particularly the LHA-VTA pathway, and its role in excessive alcohol consumption. Using
cutting-edge tools, including the OxLight1 biosensor for real-time orexin monitoring, optogenetics for pathway-
specific neuronal silencing, and whole-cell patch-clamp electrophysiology, this study will elucidate the functional
changes in orexinergic activity in male and female mice following chronic intermittent ethanol (CIE) exposure.
The innovative approach includes sex-specific and within subject analyses and behaviorally guided experiments
to address critical gaps in the field. Aim 1 of this proposal will determine how silencing LHA orexinergic neurons
projecting to the VTA modulates voluntary alcohol consumption in ethanol-dependent mice. Aim 2 of this proposal
will assess functional adaptations in the LHA orexinergic circuits to regions implicated in AUD following ethanol
dependence and their impact on voluntary alcohol consumption. The expected outcomes will reveal how chronic
alcohol exposure alters orexinergic signaling, contributing to excessive drinking and relapse. These findings will
enhance our understanding of AUD's neural mechanisms, identify potential sex differences, and detect
therapeutic strategies targeting orexinergic pathways. This research holds significant translational potential,
advancing efforts to mitigate the global burden of AUD.

Public health relevance
Project Narrative Chronic alcohol (ethanol) exposure results in changes in brain structure and function that contributes to long- term excessive drinking behaviors. I hypothesize that chronic ethanol exposure increases the neural activity of orexinergic neurons projecting from the lateral hypothalamic area to the ventral tegmental area that leads to ethanol misuse. Utilizing cutting-edge scientific approaches, I will identify and characterize changes in the orexinergic neurons that innervate the ventral tegmental area and their role in excessive ethanol drinking.